ClinGen Expert Curation Panel for the Epilepsies

PROJECT SUMMARY
The epilepsies affect up to 1% of the global population and more than 150 genetic etiologies have been
discovered over the last two decades. Genetic testing is emerging as a diagnostic standard and the diagnostic
yield frequently approaches 30-40% for individuals with epilepsy who receive testing. Knowledge about the
underlying genetic etiology is increasingly used for personalized medicine and a wide variety of gene-specific
treatments with novel pharmacological compounds, gene-regulating strategies such as use of anti-sense
oligonucleotides, and viral gene therapy are under development. However, information with regards to gene
validity and variant pathogenicity is often not standardized. This highlights an ongoing, critical need to assess
the validity of gene-disease relationships in the epilepsies, given that variant information is increasingly used for
therapeutic decision-making. Our ClinGen Epilepsy Gene Curation Expert Panel (GCEP) already curated nearly
120 genetic etiologies for the epilepsies and our Epilepsy Sodium Channel Variant Curation Expert Panel (VCEP)
has already modified ACMG/AMP variant criteria for ion channel-related epilepsies as the most important gene
group in the epilepsies. The current project represents an urgently needed continuation of our gene and variant
curation efforts, which we aim to accomplish through two aims. First, we will curate 100 gene-disease
relationships in the epilepsies in newly defined etiologies (Aim #1) given the ongoing discovery of novel genetic
etiologies in the epilepsies. We will use our previously developed epilepsy-specific Standard Operating
Procedures (SOPs) with regards to phenotype-based pre-curation to capture relevant clinical subgroups, novel
concepts for the inclusion of relevant model system data, and reassessment of prior curations based on updated
literature. We expect that these SOPs will allow for evidence-based classification in 90% of all genetic etiologies
according to different levels of certainty. Secondly, we will curate variants in synapse genes and continue
curation for channelopathies (Aim #2). The overall frequency, disease burden, and heterogeneity of the disorders
of the synapse has only become apparent in the last five years. We therefore will establish a new VCEP for
synapse disorders (STXBP1, SYNGAP1, DNM1, and STX1B) and modify ACMG/AMP criteria. Combining
variant curation in synapse disorders with our continued effort for variants curation in the ion channels, we plan
to curate 1,500 variants, aiming for reduced VUS rates by >20%. By the end of the proposed research period,
we will have addressed the lack of reliable, objectively reviewed information on the causative nature of newly
identified epilepsy genes and will have re-categorized a significant proportion of disease variants in synapse
disorders, jointly with our continued effort within the sodium channel VCEP. Combined with our prior work, this
will provide a much-needed foundation for the emerging era of precision medicine in genetic epilepsies.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health, as more reliable and expert-reviewed gene and variant curations are ultimately expected to translate into improved diagnostics and treatment of the common genetic epilepsies, allowing for greater personalized treatment choices. Thus, the proposed research is relevant to the purpose of the RFA, mission of the NIH, and goals of the ClinGen consortium by providing a dedicated framework to curate knowledge with respect to the genetic epilepsies, with the goal to use that knowledge to reduce the burden of neurological disease for all people.